IRACDA at the University of Kansas

Enter the text here that is the new abstract information for your application.
PROJECT SUMMARY
IRACDA at the University of Kansas: The goals of the KU-IRACDA program are to give postdoctoral scholars comprehensive, mentored training in research at KU, together with effective pedagogical preparation and meaningful instructional experiences at one of our partner teaching institutions, Haskell Indian Nations University and Kansas City Kansas Community College (KCKCC). Our ultimate goal is to place well-trained postdoctoral scholars in fulfilling academic jobs, whether centered primarily on research or on teaching.
KU has dozens of faculty active in research areas relevant to the NIGMS mission. These individuals are dedicated to training the next generation of academic scientists, and have the research infrastructure, the financial support, and the time to mentor KU-IRACDA scholars to success. Our program will recruit 4 scholars in our first year, and progressively build to a steady-state cohort of 10 scholars. Notably, one of these positions will be supported through the life of the proposed award by the KU Cancer Center.
KU has a number of ongoing training grants focused on enhancing research experiences for junior scientists. Our KU-IRACDA recruitment strategy will leverage these established programs. Our application process will select successful early-career researchers who have a strong intellectual connection with a KU mentor, a demonstrated commitment to teaching/instruction in STEM, a desire to enhance their instructional methods, and the goal of obtaining a faculty position. During their 3 years in the KU-IRACDA program, scholars will advance their careers via three interrelated sets of activities. First, scholars will receive mentoring from an accomplished KU faculty member and a small mentoring committee, and push forward cutting-edge biomedical research, resulting in the presentations and publications required to transition to a faculty position in academia. Second, under the guidance of the program MPIs and an internal Advisory Committee, scholars will work with groups on the KU campus (e.g., the Center for Teaching Excellence and the Office for Advancing Success in Science), as well as their mentors at our partner teaching-focused institutions, to gain experience with modern pedagogical tools and approaches. Subsequently, scholars will get direct experience working with students in the classroom, teaching courses at either Haskell or KCKCC. Especially for scholars focused on a teaching-intensive academic position, such experiences will be invaluable preparation for their future careers. Third, via one-to-one mentor-scholar coaching, and through established courses, programs, and workshops, scholars will have access to a series of professional development opportunities. By deploying Individual Development Plans, and ensuring mentors are involved in their generation and ongoing refinement, we will help promote the career goals of our scholars via a tailored system of training activities.

Public health relevance
PROJECT NARRATIVE Great Plains and Midwestern states lack scientists with the cross-cutting training to both push forward foundational, biomedical research, and effectively educate the scholars of the future. The IRACDA at the University of Kansas (KU) seeks to address this challenge by providing postdoctoral scholars expertise in research through experiential training with an accomplished KU faculty member. Additionally, our KU-IRACDA scholars will gain instructional experience via collaborations with Haskell Indian Nations University (a local college serving members of American Indian and Alaska Native communities) and Kansas City Kansas Community College (a 2-year college based in Kansas City), where they will simultaneously act as early career mentors for students in the biomedical sciences.